ENZYMATIC REACTION MECHANISMS

DESCRIPTION (Adapted from the applicant's abstract): The proposed studies on enzymatic reaction mechanism will lead to the characterization of enzymes in microbial and parasite metabolism that may be candidate targets for new drug developments themselves or produce new pharmacology. The study of the four E. coli genes Mcb A,B,C,D that convert the 43 amino acid polypeptide microcin A into the highly potent antibiotic microcin B17 that inhibits DNA gyrase will reveal the molecular enzymology of oxazole and thiazole biogenesis from gly-ser and gly-cys dipeptide sequences and of oxazole-thiazole and thiazole-oxazole bisheterocycles from gly-ser-cys and gly-cys-ser sequences in the same 43aa precursor. These bis heterocycles are probably DNA intercalators and the mechanism of enzymic formation has been obscure to date. Characterization of the E. coli acyl carrier protein synthase (ACPS) will provide molecular understanding of protein recognition of this posttranslational conversion of specific serine residues into P- pantetheinyl groups that serve as obligate prosthetic groups in macrolide, depsipeptide, and nonribosomal peptide antibiotic biogenesis. The third project, analysis of the bifunctional glutathionylspermidine (Gsp) synthetase/amidase of E. coli and congeneric Gsp synthase and bis- Gsp (trypanothione) synthase in kinetoplastid parasites, will reveal molecular strategy for formation of this unusual pair of glutathionyl polyamine metabolites in these parasitic protozoa, a pathway that should sensitize trypanosomatids to oxidant stress.